Strategic Scientific Pilot Support

Given the rapid pace of development of advanced technologies (genomics, proteomics, nanotechnologies, targeted imaging, etc.) and associated explosion of data generation, current methods and approaches are quickly becoming obsolete